Cardiovascular Disease Epidemiology in Patients with Lupus

PROJECT SUMMARY/ABSTRACT
Dr. Karen Costenbader is a recognized patient-oriented investigator in the epidemiology and outcomes of
systemic lupus erythematosus and rheumatoid arthritis, and a very engaged mentor of the next generation of
patient-oriented clinical investigators. She has served as primary or secondary research mentor for 40 pre- and
post-doctoral research trainees. Along with her position as Director of the Brigham and Women's Hospital
Lupus Program, Dr. Costenbader's mentoring is facilitated by her affiliations with multiple Harvard-based
institutions and training programs, and with national research and clinical organizations. The candidate's many
ongoing patient-oriented research projects and collaborations, high degree of commitment to mentoring and to
continuing to improve her mentoring skills, and the exceptional institutional resources, provide an outstanding
environment for the development of junior investigators. This K24 grant would preserve Dr. Costenbader's
protected time and relieve her of clinical and administrative responsibilities. The new research aims proposed
will build upon past work on cardiovascular disease risk among lupus patients. With data on more than
100,000 lupus patients enrolled in Medicaid in the U.S., the new studies will address key unanswered
questions about lupus disease heterogeneity and cardiovascular disease risk, with abundant statistical power to
detect differences in these serious outcomes. The inherent sociodemographic variation of this population and
the high risk of cardiovascular disease in this vulnerable population make these studies extremely relevant for
improving care and outcomes for lupus patients. Additionally, validating and refining the 2017 QRISK3
cardiovascular disease risk prediction algorithm in the Brigham and Women's Lupus Cohort will provide patient
interactions to collect and verify outcomes, and experience for mentees with developing risk prediction
algorithms. The clinical questions to be examined will afford independent projects and publications, experience
with advanced biostatistical models for research mentees, and excellent mentoring opportunities. Dr.
Costenbader has assembled a strong team of highly qualified co-mentors and she will recruit two to three new
trainees into her rheumatic disease epidemiology and outcomes research program annually. She will continue
to refine her mentoring program and skills using trainee feedback and the many educational opportunities in
her environment. This K24 grant would support Dr. Costenbader's ability to develop the next generation of
patient-oriented rheumatic disease investigators.

Public health relevance
PROJECT NARRATIVE Dr. Karen Costenbader is a recognized patient-oriented investigator in the study of rheumatic diseases, in particular systemic lupus erythematosus and rheumatoid arthritis, and a very engaged research mentor. The new research proposed on cardiovascular disease risks and outcomes among patients with lupus in the U.S. has great public health relevance and will afford excellent mentoring opportunities. With strong institutional commitment and resources, a strong highly-qualified co-mentoring team, and her past success in training academic clinical investigators, this K24 grant would relieve Dr. Costenbader of clinical and administrative responsibilities and greatly support her ability to mentor the next generation of well-trained leaders in patient- oriented rheumatic disease research.